2024 Notch Signaling in Development, Regeneration and Disease Gordon Research Conference and Gordon Research Seminar

Project Summary
The 6th Gordon Research Conference (GRC) on Notch Signaling in Development, Regeneration & Disease (July
14 – July 19, 2024 at Bates College, Maine) will address a major unmet need in the American scientific
community by convening scientists from both academia and industry around a fundamentally important
developmental signaling pathway broadly relevant to health and disease. Although the first “Notch phenotype”
was described over a century ago, studies elucidating the molecular events responsible for Notch signal
transduction have accelerated since the early 1980s after cloning of the Drosophila Notch receptor gene.
Subsequent studies showed that Notch signaling requires cell-cell contact, established that ligand-induced
proteolysis of the Notch receptor produces a transcriptional regulator that stimulates expression of target genes,
and demonstrated that post-translational modifications are critical to modulate ligand-receptor interactions.
Studies in model organisms identified the importance of Notch signaling in numerous cell fate decisions. Human
genetic studies showed that mutations of core Notch pathway components underlie several developmental
syndromes (e.g. Alagille Syndrome, Spondylocostal Dysostosis, aortic valve disease) and adult onset diseases
(e.g. CADASIL, various heart and valve malformations), while causing or contributing to cancer initiation or
progression in a tissue-dependent manner. Beyond its role in specific organ systems, new findings have also
uncovered a role for Notch in immune, inflammatory and metabolic disorders. Notch-targeted antibodies and
pathway inhibitors have entered clinical trials as potential anti-cancer therapeutics and are being considered for
other indications, but effective deployment of Notch modulators in the clinic continues to pose distinct challenges
around efficacy (what tumors or disease states are most likely to respond), and toxicity, because of the
importance of Notch in the homeostasis of selected adult tissues (such as the gut). Building on past success,
this meeting aims to provide a vibrant US forum to stimulate cross disciplinary discussions and collaborations in
this important area of biology, nurture a sense of community among researchers, and welcome new members
into the field. The meeting program will bring together scientists from academia, biotech and the pharmaceutical
industry addressing fundamental mechanistic, developmental, clinical and therapeutic questions using cutting-
edge approaches. Invited participants include a blend of established “thought leaders” with vast institutional
memory and many early career scientists with exciting new findings. The informal and confidential environment
in GRC meetings encourages free scientific exchange of unpublished data. The inclusion and integration of a
Gordon Research Seminar (GRS) exclusively for postdocs and graduate students prior to the GRC is a particular
asset to draw new scientists into the field and encourage trainee participation. Most importantly, the combined
GRC/GRS format excels in integrating students, postdocs and investigators wishing to enter a new field, such
as the study of this important signaling pathway.

Public health relevance
Project Narrative The goal of the proposed Gordon Research Conference (GRC) and Gordon Research Seminar (GRS) on Notch Signaling in Development, Regeneration and Disease is to provide a stimulating, international and cross disciplinary forum for the dissemination and discussion of new unpublished research, concepts, and therapeutic opportunities at the forefront of Notch-related biology. The Notch signaling pathway is a central mediator of short- range inter-cellular communication in multicellular organisms, and alterations of Notch activity cause or contribute to a growing list of human developmental syndromes, adult onset diseases and cancers, expanding the interest in this pathway well beyond the boundaries of basic developmental and cell biology and into the areas of stem cell biology, cancer biology and therapeutics. Building on past success of the conference, the 6th Notch GRC/GRS will bring together a diverse community of scientists from academia, biotech and the pharmaceutical industry working in multiple model organisms and organ systems, including researchers focused on human disease, to create a stimulating scientific environment where cutting edge technologies, ideas and discoveries can be exchanged and where students and research fellows will gain exposure to leaders in the field.